Functional mapping of noncoding regulatory variants in human neuronal subtypes3.

Complex neuropsychiatric disorders, including schizophrenia and autism spectrum disorder (ASD) among others,
impose an enormous socioeconomic burden on families and on society. The pathobiological mechanisms are
largely unknown, and treatment options are limited and often incompletely effective. During the past decade,
advances in human genetics and next-generation sequencing, coupled with expanding cohort sizes, have
permitted the identification of thousands of genetic variants that influence risk for neuropsychiatric diseases.
Each disease-associated variants identified by genome-wide association studies (GWAS) could provide insights
into a biological mechanism that underlies the risk of disease in humans. However, the availability of data is not
synonymous with the presence of meaning. The challenge researchers are facing now is the derivation of
biological meaning post-GWAS. Particularly, more than 90% of the risk variants are found in the non-coding
regions of the human genome. Although the potential contribution of non-coding variants to complex human
diseases has long been speculated, it has been a major challenge to develop testable hypotheses to decipher
their role in disease etiology. Here, we propose to develop innovative multidisciplinary approaches to bridge the
gap between human genetics and experimental biology. The major hypothesis underlying the approach is that
epigenetic changes caused by non-coding variation in the cis-regulatory elements, particularly enhancers that
are platforms for sequence-specific transcription factor binding and can influence gene transcription over long
distance, may confer disease liability by disrupting gene expression. We aim to (i) annotate functionally distinct
enhancers in disease-relevant human neuronal subtypes generated by reprogramming of pluripotent stem cells,
(ii) apply the cutting-edge HiChIP technology to profile the promoter-enhancer interactions in neurons in resting
and active states, and identify the target genes of enhancers, finally, (iii) we will determine how disease-
associated variants affect enhancer activity in human neurons. Such effort will provide the foundation to map
and prioritize non-coding risk variants for future mechanistic studies. Especially, the enhancer-interactome
analysis performed in this study will provide a physical-interaction-based approach for the identification of
enhancer target genes in neurons. The information will lay the groundwork for developing testable hypotheses
to elucidate the molecular impact of risk variants in non-coding regions. Last but not least, determining how non-
coding risk variants disrupt activity-regulated gene expression in neuronal subtypes may uncover novel disease-
relevant biology not observed using the incomplete existing methodologies and resources (activity-responsive
enhancers are not possible to identify from post-mortem tissue). Once accomplished, the proposed work will
have broad impact on translating genetic discoveries into actionable biological hypotheses that can potentially
power a new round of development of novel therapeutics strategies for complex neuropsychiatric disorders.

Public health relevance
The goal of the current application is to characterize functionally distinct non-coding regulatory elements in major neuronal types for which rare and common variant risk loci are most enriched in neuropsychiatric disorders, identify their target genes, and elucidate how noncoding variants affect the transcription of key genes for neuronal cell identity and activity-regulated signaling networks. The proposed research has the potential to develop an innovative approach and unravel the neurobiological functions of the vast but in the brain largely unexplored non-coding sequences of the human genome, which is relevant to the mission of NIH to acquire new knowledge to help prevent, detect, diagnose, and treat disease and disability.